Exploring the physicochemical properties governing compound efflux in Gram-negative bacteria

Project Summary
Multi-drug resistant infections are a major threat to global health and resistance has been observed for
every clinically-used antibiotic, even those considered to be the last lines of treatment. Further compounding
the antimicrobial resistance crisis is the lack of new antibiotics entering the pipeline, particularly for Gram-
negative pathogens which have an impermeable outer membrane, limiting small molecule accumulation, and
promiscuous efflux pumps, which can recognize and expel most small molecules from the cell. A basic-science
understanding of favorable chemical properties required to enhance compound accumulation and decrease
efflux propensity is needed to develop antibacterial candidates with whole-cell activity against Gram-negative
pathogens. Initial efforts in the Hergenrother lab have identified the physicochemical traits needed for
compound permeation in E. coli and successfully applied these guidelines to convert several Gram-positive
only antibiotics to broad-spectrum agents. While this strategy improves Gram-negative antibacterial activity,
compound efflux is still detrimental to efficacy and prevents development of these leads into potent antibiotics.
It is imperative to understand the physicochemical properties governing compound recognition and efflux to
provide a novel design platform to engineer efflux susceptibility out of drug candidates. The objective of this
proposal is to identify the parameters that define compound efflux in Gram-negative bacteria and apply these
findings to remove efflux liability out of promising antibacterial candidates.
Work proposed herein will build upon preliminary studies of the efflux propensity of ~200 compounds
utilizing a novel LC-MS/MS-based accumulation (Efflux Propensity EvaLuation (EXPEL)) assay which can
detect small changes in efflux susceptibilities irrespective of antibacterial activity and a chemoinformatic model
which can accurately classify 50% of compounds as efflux substrates and non-substrates. In Specific Aim 1,
additional physicochemical properties determined important for compound efflux by the random forest model
will be probed through synthesis of a targeted library of side-by-side comparisons. These compounds will be
added to the dataset and iterative cycles of compound synthesis, EXPEL assay, and chemoinformatic model
validation will be performed. Utilizing the EXPEL assay and the initial properties identified as correlating to
efflux ratios, derivatives of an exciting FabI inhibitor will be explored to identify promising antibacterials with
decreased efflux liabilities in Specific Aim 2. The therapeutic potential of these compounds will be explored
through toxicity studies, determination of pharmacokinetic profile, and evaluation of efficacy in mouse infection
models. Specific Aims 1 and 2 will run concurrently and completion of these studies will significantly impact
antibacterial research and remedy attrition points in the antibacterial clinical pipeline.

Public health relevance
Project Narrative The rapid rise in antibiotic resistance coupled with a dwindling antibacterial pipeline, particularly for Gram- negative pathogens, has collectively contributed to multi-drug resistant infections being deemed one of the biggest threats to global health. While recent advances have led to an understanding of the physicochemical traits guiding compound entry in Gram-negative bacteria, promiscuous compound efflux still remains poorly understood and is detrimental to antibacterial activity. This proposal seeks to define features necessary for compound recognition and expulsion by efflux pumps in E. coli and to codify these physicochemical properties into actionable guidelines for engineering efflux liabilities out of antibacterial candidates.